Epidermal Desmosomes Connect Stratification and Inflammation through Actin Remodeling

Project Summary
The evolution of cadherins enabled terrestrial metazoans to develop complex tissue barriers, with desmosomal
cadherins anchoring elastic and tough intermediate filaments (IF) to the plasma membrane at cell-cell
junctions, thus providing mechanical strength to tissues and organs. Uniquely expressed in stratified epithelial
keratinocytes, the desmosomal cadherin, Desmoglein 1 (Dsg1), also has more recently appreciated functions
in driving the process of stratification through cell delamination and suppressing inflammatory signaling.
Surprisingly, these Dsg1-dependent functions may be mediated by shared molecular machinery comprising
Arp2/3-associated actin remodeling proteins. Previous studies from my lab demonstrated that Dsg1 recruits
an Arp2/3 complex to promote actin polymerization at desmosomes, facilitating keratinocyte migration to the
next superficial layer by altering cell mechanics in the stratifying cell. However, the mechanism by which Dsg1
maintains Arp2/3 at the plasma membrane remains unclear. My data points to a role for Nck1, an adaptor
protein known to facilitate Arp2/3 activation via N-WASP, which was identified as a potential desmosome
interactor in a publicly available proteomic screen. Our data suggest that Dsg1 recruits Nck1 to desmosomes
through Dsg1 Y1042, enabling interactions with N-WASP and Arp2/3 at the plasma membrane. Silencing Nck1
or introducing a Y1042F mutation in Dsg1 impairs epidermal stratification, suggesting that Dsg1 regulates actin
remodeling via N-WASP through tyrosine phosphorylation at the Nck1 binding site. Notably, the Nck1
associated protein, N-WASP is also present in the nucleus, where it can suppress the expression of
inflammatory cytokines, including IL-23, known to cause inflammation in Dsg1-deficient patients and in the
common inflammatory disorder psoriasis. These data lead to my hypothesis that through Nck1, Dsg1 recruits
N-WASP/Arp2/3 complex in a non-receptor tyrosine-kinase (NRTK) dependent fashion to control stratification
and, through downstream signaling, directs N-WASP to the nucleus to help manage inflammation. In Aim 1 I
will determine how Dsg1 recruits the N-WASP-actin complex to the membrane to drive actin remodeling for cell
delamination using assays to assess protein-protein interactions, actin polymerization, and keratinocyte
stratification. In Aim 2 I will elucidate how Dsg1 governs N-WASP localization and stability through
serine/threonine kinase signaling to modulate inflammatory pathways using live cell imaging, cell fractionation
and analysis of keratinocyte cytokine expression. These studies promise to reveal how Dsg1 integrates its
roles in creating the physical and immune barriers through shared mechanisms and may reveal new
therapeutic avenues for strengthening and repairing the epidermal barrier.

Public health relevance
Project Narrative This work explores how a protein called Desmoglein 1 (Dsg1) not only holds skin cells together but also plays important roles in skin regeneration and inflammation control. Dsg1 helps skin cells move to the surface by organizing specific molecules that guide cell structural changes, and using the same molecules may prevent inflammation by controlling activity of gene expression machinery. Understanding how Dsg1 manages these processes could lead to new treatments for skin disorders where Dsg1 is missing or dysfunctional.